Data Management and Statistics Core

PROJECT SUMMARY
The success of research studies in any human disease, but particularly Alzheimer's disease (AD) and
AD-related dementias (ADRD), is critically dependent on the collection, generation, management, analysis, and
interpretation of large, varied, and detailed data sets. The overall goal of the Data Management and Statistical
Core (DMSC) is to empower AD/ADRD researchers to acquire, manage, analyze, and interpret their data. To
do this, we leverage existing institutional infrastructure and provide the necessary expertise for the Cleveland
Alzheimer's Disease Center (CADRC). This goal will be accomplished through three specific aims.
Specific Aim 1 provides a comprehensive data management platform for the collection, aggregation, and
management of the relevant data. We will leverage the infrastructure of the Cleveland Institute for Computational
Biology (CICB), which has developed a safe and secure computational environment for data capture and
management that is available to all the participating institutions (the SHED [Safely Held Electronic Data] data
management system). The SHED uses a tier III secure computational environment along with both
computational and policy access and privacy controls. The system easily integrates a wide variety of data
formats and provides methods for participant and sample tracking for longitudinal studies. Comprehensive
training for CADRC personnel is provided.
Specific Aim 2 enhances interactivity with the other cores, investigators, and external databases.
Through the efforts of the Administrative Core, participating institutions have institutional agreements to capture
and share electronic data through the SHED. All investigators and staff across the CADRC institutions have
controlled access to the SHED. We have put into place processes internally for interacting with each of the
CADRC cores, and externally for interactions with databases and users such as the National Alzheimer's
Coordinating Center (NACC) and the National Institute for Aging Genetics of Alzheimer's Disease Data Storage
site (NIAGADS).
Specific Aim 3 provides biostatistical, study design, and data analysis support to the CADRC. The DMSC
provides support for these activities through access to a wide range of expertise including biostatistical (Drs.
Tatsuoka and Feng), genomic (Drs. Haines and Feng), and imaging (Dr. Tatsuoka). Dr. Feng also brings
expertise in data integration and machine learning to the CADRC. Substantial technical support will be provided
by a master's level analyst.
The DMSC is well positioned to accommodate the data management and data analysis needs of the
CADRC, its investigators, and the broader AD/ADRD research community.